PKD proteins in endothelial cells

Project Summary
Endothelial cells line the wall of all blood vessels and regulate a wide variety of functions, including contractility
which controls systemic blood pressure. Dysfunctional endothelial cells are a hallmark of several
cardiovascular diseases, but pathological mechanisms involved are poorly understood. Endothelial cells
express both PKD1 (polycystin-1), an eleven transmembrane domain protein, and PKD2 (polycystin-2), a
transient receptor potential (TRP) channel. Regulatory mechanisms, physiological functions and pathological
involvement during hypertension of PKD1 protein and PKD2 channels in endothelial cells are unclear. Using a
wide variety of approaches and inducible, endothelial cell-specific knockout mice, we provide evidence that
physical coupling of PKD1 to PKD2 in endothelial cells stimulates vasodilation. Preliminary data also suggest
that PKD1/PKD2 channel signaling is dysfunctional during hypertension, which attenuates this vasodilatory
signaling mechanism. In this proposal, we will investigate three specific aims. Aim 1 will test the hypothesis
that endothelial-dependent physiological stimuli activate PKD1/PKD2 coupling in endothelial cells, leading to
vasodilation. Aim 2 will investigate the mechanisms by which endothelial-dependent stimuli activate
PKD1/PKD2 channels in endothelial cells to produce vasodilation. Aim 3 will study the hypothesis that
hypertension is associated with pathological alterations in PKD1/PKD2 channel signaling in endothelial cells
that inhibits vasodilation mediated by these proteins. Methods used will include RT-PCR, Western blotting,
biotinylation, FRET, RNAi, co-IP, immunofluorescence, patch-clamp electrophysiology, membrane potential
recording, intracellular Ca2+ imaging, arterial myography and blood pressure telemetry. This project will
provide significant novel information concerning vasoregulation by endothelial cell PKD1 and PKD2 proteins.

Public health relevance
Project Narrative Endothelial cells regulate arterial contractility. Dysfunctional endothelial cell control of contractility is a hallmark of several cardiovascular diseases, including hypertension, but pathological mechanisms involved are poorly understood. We will investigate the novel hypothesis that PKD1 and PKD2 proteins regulate arterial contractility, investigate signaling mechanisms involved and test the concept that vasodilation mediated through these pathways is dysfunctional during hypertension.